HTLV-III SEQUENCES AT THE TRANSCRIPTIONAL LEVEL

Opportunistic viral infections are prevalent in patients with acquired immune deficiency syndrome (AIDS). To investigate the possibility that opportunistic infections in the herpesvirus group might induce expression from the human T-lymphotropic virus type III (HTLV-III) long-terminal repeats (LTR), we constructed permanent cell lines (murine and simian), containing the HTLV-III LTR directing the chloramphenicol acetyltransferase (CAT) gene. Whereas in transient gene expression assays, the HTLV-III LTR express CAT activity as high as the simian virus-40 (SV40) early promoter, no CAT activity is observed after chromatin integration in permanent cell lines. Superinfection of these latent HTLV-III LTR containing lines with herpes viruses reactivated the HTLV-III LTR as determined by S1 nuclease RNA analysis. Whereas simian virus-40 (SV40) and adenovirus infection of the latent HTLV-III LTR containing cell lines did not activate HTLV- III LTR expression. Reactivation of latent HTLV-III LTR transcription is also observed after 5 azacytidine, cycloheximide and UV irradiation treatments. Run-on transcription in isolated nuclei, suggests that the activation is on the transcriptional level. Activation by herpes simplex virus type 1 (HSV-1) required viral immediate early (IE) gene expression as determined by virus infection in the presence of cycloheximide and with mutants defective in viral gene expression. The long-term objective of the research described in this proposal is to elucidate the mechanism(s) by which the HTLV-III LTR could be activated on the transcriptional level. The specific aims are to identify the viral gene products responsible for latent HTLV-III LTR transcription activation; to establish permanent cell lines in human B and T-cells containing the HTLV-III LTR; to identify the mechanism(s) of repression of the HTLV-III regulatory region and to define the HTLV-III LTR DNA sequences involved repression and reactivation. The preliminary results suggest that opportunistic infection of the herpesvirus group could induce HTLV-III expression in individuals harboring the virus in a latent form and points to the potential of these cell lines to study the affects of other physiochemical stimuli on HTLV-III reactivation.